Novel compounds for the treatment of systemic sclerosis-associated interstitial lung disease

PROJECT SUMMARY / ABSTRACT
Systemic sclerosis interstitial lung disease (SSc-ILD) is a progressive orphan disease highlighted by pulmonary
fibrosis leading to a high mortality rate. Currently, there are only two FDA approved SSc-ILD therapies (OFEV
and ACTEMRA), both of which have limited efficacy and are mired with safety issues, warranting the
development of novel therapeutic targets to treat SSc-ILD. Our preclinical work has identified TGFβ-activated
kinase 1 (TAK1) as a key signaling element in fibroinflammatory signaling observed in pulmonary fibrosis. TAK1
plays a critical role in facilitating activation of protein kinase-mediated signaling pathways implicated in the
pathogenesis of SSc-ILD, and as a result has emerged as a novel target for regulating SSc-ILD mediated
inflammation and fibrotic signaling. Our recent discovery of the takinib scaffold has identified a highly selective
(selectivity score = 0.037), potent (IC50 = 2.5nM), and orally bioavailable (%F = 98%) small molecule inhibitor of
TAK1 (HS-276). Preclinical studies have demonstrated that TAK1 inhibition attenuates critical TGFβ fibrotic
signaling in human-derived fibroblasts, as well as limits pro-inflammatory cytokine signaling in activated human
macrophages. Furthermore, HS-276 significantly reduced bleomycin-induced pulmonary fibrosis, in vivo. Here,
we will build upon these foundational proof of concept studies and further develop HS-276 for the treatment of
SSc-ILD. In order to successfully further develop our program, this project includes the following Specific Aims:
Aim 1: In vivo pharmacodynamic studies with HS-276 in two distinct murine lung fibrosis models: (Bleomycin
and Tsk1/+). Aim 2: HS-276 safety in bacterial and fungal opportunistic disease models. Aim 3: Completion of
key GLP safety and toxicology studies required for submission of an IND. Following successful completion of
these aims we will be poised to advance HS-276 towards Phase I clinical trials for the treatment of SSc-ILD.

Public health relevance
PROJECT NARRATIVE Development of an orally bioavailable inhibitor of the protein kinase TAK1 should have a major impact on systemic sclerosis-associated interstitial lung disease (SSc-ILD) treatment strategies by broadening the landscape of therapeutic options for these patients. Current standard of care for SSc-ILD is primarily symptom- based with limited efficacy, and no treatment has been shown to alter disease progression or reduce mortality, leading to an increased burden on the quality of life of patients and higher costs to the US healthcare system and economy at large. Providing the SSc-ILD market with a novel alternative to current treatment options (such as a TAK1 inhibitor) which is safer and more effective than current products, will significantly improve the quality of care for SSc patients in the US and across the globe.